Leveraging arginase biology against metabolic disease

ABSTRACT
Intermittent fasting and caloric restriction are effective therapies against insulin resistance, non-alcoholic fatty
liver disease (NAFLD) and non-alcoholic steatohepatitis (NASH). Yet, intensive lifestyle modifications are rarely
sustainable. We made the provocative discovery that modulating systemic arginine status is sufficient to mimic
the therapeutic effects of generalized caloric restriction on hepatic steatosis. This is clinically significant,
because targeting arginine is a tractable pathway through which to treat metabolic disease. Accordingly, our
long-term goal is to define the signaling cascades underlying adaptive hepatic glucose fasting, so that we can
identify new therapies that leverage these pathways against NAFLD and NASH. Our unbiased transcriptomic
screening in fasting mice identified a novel glucose fasting-induced effector: the amino acid hydrolase, arginase
2 (Arg2). Our new data demonstrate that forced hepatocyte-specific Arg2 expression reduces peripheral insulin
resistance, hepatic steatosis, and inflammation in diabetic mice. Because hepatocyte arginine fate depends upon
competition between Arg2 and the lysosomal arginine sensing machinery that dictate autophagic flux, and the
pro-inflammatory enzyme, inducible nitric oxide synthase (iNOS), we hypothesize that fasting-induced
hepatocyte Arg2 attenuates hepatic steatosis and inflammation by depleting hepatocyte arginine. To test this,
we will: 1) examine pleiotropic therapeutic mechanisms of Arg2 action against insulin resistance and hepatic
inflammation; 2) examine small-molecule and advanced biological therapeutics that mimic the therapeutic
actions of Arg2 activation and 3) define their mechanistic underpinnings. Completing these aims will: 1) establish
arginine status as a determinant of metabolic homeostasis; 2) identify how modulating arginase activity impacts
cellular lysosomal sensing and its physiological outcomes; and 3) examine efficacy and mechanisms of novel
therapies to NAFLD, NASH and insulin resistance.

Public health relevance
PROJECT NARRATIVE Fasting and caloric restriction are effective to treat patients with pre-diabetes or non-alcoholic fatty liver disease (NAFLD), but intensive lifestyle changes are difficult for many to implement and sustain. We discovered a key pathway in the liver, which is activated during fasting, and which is sufficient to treat pre- diabetes and NAFLD in mice. In this proposal, we will define how Arg2 mediates its effects, and examine bring forth new therapies that mimic the actions of Arg2 to ultimately treat obesity-related metabolic disease.